CLINICAL TRIAL OF GENE THERAPY OF GAUCHER DISEASE

The hypothesis of this study is that genetically corrected peripheral blood stem cells (PBSC) will result in a sustained reversal of the phenotype in patients with Gaucher disease. Specific aims to be achieved are the transfer of the human GC gene into PBSC obtained from patients with Gaucher disease, the transplantation of transduced PBSC autogously to patients and the measurement of carriage & expression of transferred gene & its duration in peripheral blood luekocytes (PBL) and the assessment of clinical effects of transplanting genetically corrected PBSC in patients with Gaucher disease.